HPV Serology

The Contractor shall conduct and support projects in collaboration with a variety of partners. Tasks include but are not limited to: supporting development of serological standards, reagents, and assays; analyzing vaccine responses in clinical specimens; biospecimen and clinical data collection; coordinating sharing of biomedical data; assessing, piloting, and implementing new technologies; engaging with the cancer research community; tracking and monitoring dedicated budgets; assessing equipment and associated maintenance needs; project procurement; subcontracting agreements; and overall coordination of administrative program level functions. Partners may include intramural and extramural investigators and other federal agencies.